Characterizing the mechanistic basis for sex-dimorphic responses to retinoic acid signaling in the developing brain

Project Summary/Abstract
Sex hormones and sex chromosome genes instruct development of sex-specific features during
neurodevelopment, including differences in somatic gene expression and gray matter volume. Together, these
developmental programs lead to fundamental differences at the molecular, cellular, and tissue level between
males and females. While some neurological disorders have clear links to X chromosome genes, such as Rett
Syndrome and Fragile X Syndrome, other disorders including Autism show sex-biased penetrance with no
clear genetic mechanism. This proposal aims to address the mechanistic basis of sex-dimorphic transcriptional
responses to retinoic acid signaling in the developing brain. Retinoic acid signaling is indispensable for
modulating gene regulatory programs that orchestrate proper nervous system development, and recent work
has shown that the Autism risk gene FOXP1 is upregulated in response to retinoic acid signaling. Preliminary
studies have shown specific upregulation of FOXP1 in response to retinoic acid signaling in female cortical
organoids, and not in males. This project will similarly leverage stem cell-derived cortical organoids to model
neurodevelopment in vitro to better understand the molecular basis of sex-dimorphic phenotypes upon
exposure to retinoic acid. Aim 1 will characterize sex-dimorphic genome wide expression changes in response
to retinoic acid. Male and female organoids will be treated with vitamin A, the precursor to retinoic acid, and
used for scRNA-seq. This dataset will uncover genes upregulated specifically in female organoids in response
to retinoic acid. Additionally, I will identify cell types in both male and female organoids that exhibit the greatest
gene expression changes in response to retinoic acid, lending insight into cell type-specific sensitives to
retinoic acid during neurodevelopment. In Aim 2, the relationship between dosage of X-linked lysine
demethylase KDM5C and retinoic acid-induced sex-specific gene regulatory programs will be characterized.
Knockdown of KDM5C in female stem cell-derived organoids and subsequent genome-wide changes in H3K4
methylation, which is demethylated by KDM5C, will be determined by CUT&Tag. A putative enhancer at the
FOXP1 locus coincides with H3K4me3 marks, and KDM5C-dependent methylation at this genomic site will be
of particular importance. The impact of KDM5C knockdown on retinoic acid-induced FOXP1 expression will
then be interrogated by immunohistochemistry. Together, these experiments will further our understanding of
the intersection of epigenetics, gene expression, and cell signaling pathways during neurodevelopment,
providing an an important mechanistic basis for sex-dimorphic developmental programs. This will further our
understanding of the etiology of neurodevelopmental disorders with sex-biased penetrance, while uncovering
potential candidates for therapeutic interventions.

Public health relevance
Project Narrative Sex differences in brain structure and sex-biased penetrance of neurodevelopmental disorders have long been appreciated, where X chromosome gene dosage contributes to sex-specific developmental programs. This project seeks to characterize how X-linked gene dosage leads to sex-dimorphic responses to retinoic acid during development, contributing to sex-specific vulnerabilities to neurological disorders. This work will provide important insights into the genes that lead to disparate developmental phenotypes in response to retinoic acid, providing insight into the etiology of neurodevelopmental disorders and uncovering possible targets for therapeutic interventions.